The primary role of low NCOA6 expression in the prostate cancer disparity among African American men

Project Summary/Abstract
Comparing with European American (EA) men, African American (AA) men have significantly higher prostate
cancer (PC) incidence, and their PCs are more likely to become castration-resistant, metastatic, and lethal. It is
still unclear what causes this AA PC disparity. Overexpressed EGFR can be oncogenic, and EGFR is more
frequently overexpressed in AA PCs compared with EA PCs, but it is still unknown what causes EGFR
overexpression (OE). We found that NCOA6, a transcription coregulator with pleiotropic functions, is frequently
downregulated in AA PCs, and its loss causes EGFR OE in AA PC cells. We also found that knockout (KO) of
NCOA6 promotes prostate epithelial hyperplasia with heterozygous Pten to develop fast-growing, invasive,
metastatic, lethal PCs in the mouse prostates. Based on these findings, we hypothesize that NCOA6 is more
frequently downregulated in AA PCs versus EA PCs, and its frequent downregulation is associated with the
frequent EGFR OE in aggressive AA PCs with poor prognosis. We also hypothesize that NCOA6 loss causes
EGFR OE, which in turn promotes castration-resistant PC (CRPC) development. In Specific Aim 1, we plan to
associate low NCOA6 expression with EGFR OE and CRPC development in AA PCs. Specifically, we will
measure and compare NCOA6 and EGFR protein expression levels in both AA and EA PCs and matched
adjacent normal prostate tissue specimens, and perform comprehensive data analysis. We hope to find higher
percentage of AA PCs with low-NCOA6 and high-EGFR expression compared with EA PCs, which will connect
the frequent NCOA6 downregulation to the development of AA PC disparity. We will also examine whether
NCOA6 loss can promote androgen-sensitive AA PC cells to develop CRPCs, and whether NCOA6 loss-
promoted CRPCs depend on EGFR OE to grow and survive. If successful, the outcomes of these studies will
associate frequent low NCOA6 expression with frequent high EGFR expression in aggressive AA PCs and
demonstrate that NCOA6 loss-caused EGFR OE plays a key role in promotion of AA CRPC development. In
Specific Aim 2, we plan to dissect the molecular events responsible for NCOA6 loss-caused EGFR OE in AA PC
cells. We found NCOA6 interacts with NFY transcription factor and associates with a distant putative EGFR
enhancer. We will carry out a cluster of experiments involving enhancer mapping, protein-protein and protein-
DNA interactions, chromatin looping, and enhancer-promoter interaction. These experiments will address how
the NCOA6:NFY complex at the putative enhancer prevents EGFR OE and how NCOA6 loss causes EGFR OE.
Collectively, successful outcomes of this project will establish a conceptual model, in which NCOA6 works with
NFY to repress the distant EGFR enhancer, which prevents EGFR OE and AA CRPC development. Frequent
NCOA6 downregulation causes frequent EGFR OE, which promotes PC and CRPC development and drives AA
PC disparity. Accomplishment of this project will also help our next phase research to develop low NCOA6 and
high EGFR as diagnostic/prognostic markers for selecting AA CRPC patients for personalized treatment.

Public health relevance
Project Narrative The epidermal growth factor receptor (EGFR) is a protooncogene frequently overexpressed in aggressive African American (AA) prostate cancers, and the nuclear receptor coregulator 6 (NCOA6) loss causes EGFR overexpression in AA prostate cancer cell lines. This R21 project intends to associate low NCOA6 expression with EGFR overexpression in aggressive AA prostate cancers, and to demonstrate that this associated expression can strongly promote castration-resistant prostate cancer development from androgen-sensitive AA prostate cancer cells. This project will also elucidate the mechanism responsible for NCOA6 loss-caused EGFR overexpression in AA prostate cancer cells.